Enhancing operational efficiency and animal welfare through the use of digital ventilated caging for laboratory mice in an ABSL3 Select Agent biocontainment program

PROJECT SUMMARY
This proposal seeks funding to acquire four Techniplast Digital VenƟlated Cage (DVC) Isocage NegaƟve
systems, a crucial step in upgrading mouse housing and improving husbandry pracƟces while
simultaneously enhancing animal welfare in our shared Animal Biosafety Level 3 (ABSL3) Plus Select
Agent program at St. Jude Children's Research Hospital (SJCRH). SJCRH's ambiƟous strategic plan for the
ﬁscal years 2022‐2027 outlines a substanƟal 54% increase in faculty members (from 91 to 140) expected
to uƟlize in vivo research resources. This expansion is aligned with the insƟtuƟon's mission to establish a
world‐leading research eﬀort in infecƟous diseases that aﬀect children. To achieve this goal, we intend to
recruit sixteen new faculty members who specialize in laboratory‐based research on infecƟous diseases
and immunity. They will complement the exisƟng faculty of nine, who are engaged in cuƫng‐edge
research in areas such as inﬂuenza, SARS‐CoV2, pneumococcal infecƟons, viral and bacterial
therapeuƟcs, and the funcƟons of adapƟve and innate immunity during these infecƟons. AddiƟonally,
SJCRH serves as one of the collaboraƟng centers for the World Health OrganizaƟon's Global Inﬂuenza
Response and Surveillance System, funcƟoning as the Center for Studies on the Ecology of Inﬂuenza in
Animals and Birds. Moreover, our program is funded as a Center of Excellence for Inﬂuenza Research and
Response (CEIRR) through grants from the NaƟonal InsƟtute of Allergy and InfecƟous Diseases (NIAID).
Considering these commitments and aﬃliaƟons, the ABSL3 facility plays a pivotal role in supporƟng
these criƟcal iniƟaƟves. The primary objecƟve of this project is to replace the aging Mouse
Biocontainment Individually VenƟlated Caging (IVC) system, which was procured back in 2002. We aim to
replace it with the state‐of‐the‐art Techniplast DVC system, which oﬀers real‐Ɵme monitoring of rack
blower funcƟons, intra‐cage condiƟons, and animal acƟvity. This conƟnuous monitoring will allow for the
opƟmizaƟon of husbandry pracƟces and improved veterinary care, ulƟmately leading to more humane
endpoints. Furthermore, it will facilitate the Ɵmely collecƟon of Ɵssue and ﬂuid samples and data,
especially in situaƟons when access to the facility is restricted—such as weekends, holidays, or during
severe weather‐related conƟngencies that can aﬀect staﬃng levels. The DVC racks come with four Ɵmes
the backup baƩery life (up to 36 hours) compared to the current system. The DVC system oﬀers detailed
monitoring and immediate noƟﬁcaƟon of supply and exhaust air parameters, signiﬁcantly improving our
ability to respond eﬀecƟvely during unforeseen conƟngencies. As a result, this grant proposal promises
to substanƟally enhance the operaƟonal eﬃciency and overall animal welfare in our ABSL3 facility. It will
enable us to opƟmize the allocaƟon of resources to meet the increasing demands of current and future
invesƟgators at SJCRH.

Public health relevance
PROJECT NARRATIVE This proposal is to request funds to purchase four Techniplast Digital VenƟlated Cage (DVC) Isocage NegaƟve systems to upgrade mouse housing, opƟmize husbandry and enhance animal welfare in the shared Animal Biosafety Level 3 (ABSL3) facility at St Jude Children's Research Hospital (SJCRH). This facility is a criƟcal resource for invesƟgators engaged in infecƟous disease and immunity research including the NIAID funded Center of Excellence in Inﬂuenza Research and Response (CEIRR). The goal of this project is to replace the exisƟng 21‐year‐old Mouse Biocontainment rack system with state‐of‐the‐ art Techniplast DVC biocontainment system capable of monitoring rack blower funcƟons with extended back‐up power and capabiliƟes for sensing intra‐cage condiƟons and animal acƟvity for opƟmal delivery of husbandry and veterinary oversight.